Behavioral Intervention Development Core

PROJECT SUMMARY – BEHAVIORAL INTERVENTION DEVELOPMENT CORE
The proposed Behavioral Intervention Development (BID) Core of Cornell’s Roybal Center–The
Translational Research Institute on Pain in Later Life (TRIPLL)-- will maintain and extend the strategies
TRIPLL’s investigator development program employed over the past 5 years to achieve measurable success.
TRIPLL will support the development and execution of trials that seek to develop and test scalable, efficacious,
and effective behavioral pain treatments for older adults targeting concrete Mechanisms of Behavior Change
(MoBC). This research is crucial given that current behavioral approaches to manage pain provide small-to-
moderate benefits, the mechanisms underlying existing behavioral interventions remain poorly defined, and
few behavioral pain management strategies in this area have advanced beyond the efficacy stage of
development. Cornell’s Roybal Center will focus its translational research efforts on underrepresented
populations, i.e., older adults with cognitive impairment, minority elders, and older adults living in rural areas.
TRIPLL’s BID Core will bring together theoretical and methodological leadership from its team of highly skilled
investigators, External Advisory Committee, Internal Advisory Committee, and Industry Advisory Board to
achieve these goals, conducting national competitions to identify and fund clinical trials that have the potential
to advance to Stages III-V of the NIH Model, consulting with investigators to develop potent and scalable
interventions, ensuring timely project progress and research integrity, assuring timely dissemination of
research results to appropriate audiences, and providing continued methodological support well beyond
completion of the initial study to advance the trial to higher stages. Cornell Roybal Center’s overarching goal is
to disseminate behavioral interventions that measurably improve the health and well-being of aging adults
adversely affected by pain. In the proposed continuation, the specific aims of the Cornell Roybal Center’s BID
Core are to: 1) Maintain a responsive leadership and administrative infrastructure to support intervention
development for later-life pain across the NIH Stage Model; 2) Support and monitor innovative clinical trials
that are anchored in the Mechanisms of Behavior Change MoBC and strive to ensure applicability in
demographically diverse, underrepresented groups; and finally 3) Leverage the intellectual, fiscal, and other
resources of the academic and industry collaborators in this application and foster new collaborations with
other NIA-funded Centers to achieve synergistic results that would not be attainable by any one institution.
The aims of TRIPLL’s BID Core are significant because behavior change interventions will ultimately be
more effective if the underlying mechanisms driving behavior change are clearly understood. Finally, TRIPLL
pilot studies will leverage new theoretical innovations in the social/behavioral sciences to improve the efficacy,
effectiveness, and dissemination of interventions implemented in aging populations adversely affected by pain.